Repurposing FDA-Approved Drugs to Target Chronic Alcohol Tolerance

Abstract
Alcohol Use Disorder (AUD) is a complex brain disease characterized by excessive alcohol consumption,
leading to severe consequences and chronic tolerance, where increasing amounts of alcohol are needed to
achieve the same effects. Understanding the mechanisms of chronic tolerance is crucial for developing effective
treatments yet remains challenging. Compounds targeting serotonin signaling, such as psychedelics, have
shown potential for treating AUD. However, their mechanisms of action are not fully understood, and drugs with
histories of abuse or controversy face significant challenges in gaining clinical acceptance, often requiring
additional time and costs for regulatory approval. To surmount this hurdle, we propose the development of a
rapid and reliable platform for the evaluation and repurposing of compounds, including FDA-approved drugs, for
the treatment of AUD and comorbidities. We employ the nematode Caenorhabditis elegans as an AUD model,
effectively replicates key features of AUD, providing valuable insights into its neural and molecular underpinnings.
Our goal is to identify compounds that suppress chronic ethanol tolerance and dependence. Using the FDA-
approved drug library, we will conduct in vivo phenotypic screening in C. elegans, focusing on behaviors linked
to ethanol and serotonin tolerance. Additionally, we will identify the molecular components within the serotonergic
system that influence these behaviors. Our high-throughput (HTP) locomotor activity tracking system will
facilitate reliable data acquisition and comprehensive assessment of chemical impacts, accelerating the
development of novel AUD therapeutics.
In summary, our innovative approach combines endophenotypic screening with the repurposing of FDA-
approved drug libraries. This strategy offers a rapid and efficient means of gaining insights into AUD mechanisms,
ultimately advancing the development of novel therapeutics for this intricate disorder and its associated
comorbidities.

Public health relevance
Our proposal deals with the significance of alcohol sensitivity and tolerance in the context of alcohol use disorders (AUD). To comprehensively analyze complex behavioral paradigms within a simplified system, we employ a chronic alcohol tolerance and dependence model utilizing the invertebrate model organism Caenorhabditis elegans, to investigate conserved serotonergic and neuropeptide signaling pathways. Employing phenotypic high-throughput (HTP) screening, we will repurpose the FDA-approved drug library subjecting its compounds to rigorous screening processes aimed at elucidating their effects on chronic ethanol tolerance and, ultimately, dependence.